NLM Research Training Program in Biomedical Informatics and Data Science for Predoctoral and Postdoctoral Fellows

PROJECT SUMMARY/ABSTRACT
We seek renewal of our NLM Research Training Program in Biomedical Informatics and Data Science
(NLMTP), which for 29 years has consistently produced outstanding pre- and postdoctoral trainees as the
program has evolved along with Biomedical Informatics and Data Science (BMI and DS) themselves,
successfully bringing computation, data science, applied mathematics, statistics, biomedicine, modeling, data-
driven inference and decision-making, and advances in cognitive informatics, to bear on biomedical problems.
With this renewal, we will further expand our research training program to explore and exploit the dynamic
interaction of BMI and DS with artificial intelligence (AI), including machine learning, and their applications in
biomedicine and human health and disease. Our program will not only equip trainees with solid DS
methodology and the latest tools, computational approaches, and statistical methods to solve BMI problems,
but also provide broad foundations that will enable them to invent the methodologies of the future to attack
problems currently beyond our reach; this will produce a new generation of BMI scientists who can extract new
knowledge from experience and experiment to inform basic research, patient care and public health. We,
therefore, seek to train our students and postdocs to work effectively at the interface between theory and
practice, between knowledge acquisition and knowledge sharing. Our 46 training faculty, with broad expertise
in BMI, DS, and AI coupled with basic science and clinical knowledge, have a record of high research
productivity, extensive collaborations, and federal funding. Their track record of the recruitment, training, and
career advancement of underrepresented (UR) groups including women is strong, having mentored 264
predocs and 337 postdocs over the past 10 years, with 208 predocs (31% UR, 39% women) and 132 postdocs
(16% UR, 31% women) currently in their labs. Our 9 predoctoral trainees will have completed one year of study
and joined a lab at one of six participating institutions before joining the NLMTP (typically for 3-year
appointments), thus ensuring that their research projects fit well into the training areas of the NLM. Our 6
postdoctoral trainees will be selected through national recruiting and from the labs of our faculty, for typically
2-year appointments. NLMTP training will combine core courses in BMI and DS, advanced elective courses,
training in rigor and reproducibility and the responsible conduct of research, professional/career development
activities, monthly meetings with experts, and interdisciplinary dual-mentored research projects in health
care/clinical informatics, translational bioinformatics, and clinical research informatics. Our research training
program will undergo regular evaluations by external experts with adjustments made as needed. This program
will provide the perfect opportunity for trainees to acquire the skills, expertise and intellectual abilities to foster
innovative research and prepare them for applied research or related careers in which they can profoundly
affect such critical areas as personalized medicine, clinical decision making, and data-driven health.

Public health relevance
PROJECT NARRATIVE Our NLM Research Training Program in Biomedical Informatics (BMI) and Data Science (DS) has successfully brought the theory and practice of computation, applied mathematics, statistics, data-driven inference and decision-making, and advances in cognitive informatics, to bear on problems in human health and disease that are currently beyond our reach. We will further expand our program to explore and exploit the dynamic interaction of multiple facets of BMI and DS with the current methodologies, tools, and computational approaches of artificial intelligence including machine learning, and their synergistic applications in biomedicine and human health and disease, including precision medicine, clinical decision-making and data-driven health. This program provides the unique opportunity for pre- and postdoctoral trainees to acquire the skills, expertise and intellectual abilities to foster innovative research and prepare them for a wide range of BMI careers that significantly impact basic research, patient healthcare, and public health, by: pursuing core courses in BMI and DS and advanced electives, training in rigor and reproducibility and the responsible conduct of research, professional/career development activities, and dual-mentored inter-disciplinary research projects in health care/clinical informatics, translational bioinformatics, and clinical research informatics.